Evaluation of didehydro-Cortistatin A as a block-and-lock agent for a functional HIV cure in a macaque model

Abstract
A reservoir of latently infected cells persists in various anatomical sites in people living with HIV (PLWH),
despite effective virological control by antiretroviral therapy (ART). The majority of virally suppressed individuals
experience rapid viral rebound upon ART interruption, providing a strong rationale for the development of cure
strategies. Even in an ART-suppressed HIV infection, chronic inflammation and immune activation are observed,
along with limited CD4+T cell reconstitution, mucosal immune dysfunction, co-morbidities, and accelerated
ageing. Low-grade persistent transcription and trickling production of viral proteins from the pool of integrated
proviruses are believed to be partly responsible for these conditions. HIV eradication strategies such as shock-
and-kill have not been successful so far, and the pursuit of a functional cure or HIV remission has been thought
as an alternative worth exploring. A functional cure entails long-term, durable control of viral expression in the
absence of therapy, preventing disease progression and transmission, despite the presence of detectable
integrated proviruses. Our group has been at the forefront of developing one such strategy, labeled the block-
and-lock approach. The premise of this approach is that transcriptional inhibitors can mediate epigenetic
silencing of proviral expression, locking the virus in a profound state of latency from which reactivation is very
unlikely to occur upon ART discontinuation. We have demonstrated this principle using the small molecule
didehydro-Cortistatin A (dCA) inhibitor of Tat, the key regulator of HIV transcriptional amplification. In in vitro and
in humanized mouse models of HIV latency, dCA inhibition of HIV transcription over time drives the viral promoter
into deep transcriptional inhibition, limiting viral reactivation upon treatment interruption or with latency
reactivating agents (LRAs)1–8.
We believe that HIV transcriptional inhibitors, in general, have the potential to transform the way we treat HIV-
1 infections. Here we propose to investigate the potential of adding the transcriptional inhibitor dCA to an ART
regimen in the rhesus macaque (RhM) model of SHIV infection. Not only is dCA a new molecule that inhibits the
activity of a viral target not yet clinically explored, but it also opens the possibility for exploration of novel
approaches to fight HIV. Here we propose to: 1) determine the safety and pharmacokinetics of dCA in ART-
treated RhMs; 2) understand the relationship between dCA treatment and reduction in viral RNA in tissues, with
the time to viral rebound upon treatment interruption; and 3) study the impact of dCA as front-line therapy on the
size of the established viral reservoir.

Public health relevance
Narrative The overarching goal of this project is to evaluate the activity of the Tat inhibitor, didehydro-Cortistatin A (dCA), for inhibition of HIV transcription. Tat inhibitors are not yet part of the clinical antiretroviral ammunition despite their immense potential at shutting down particle production from infected cells and blocking Tat toxicity. We expect to gain valuable insight into the potentially transformative benefits of adding HIV transcriptional inhibitors to current antiretroviral therapy, whether dCA could act as a single-therapy to block HIV expression, and whether dCA can limit virus recrudescence when therapy is interrupted.